GENETIC LINKAGE ANALYSIS IN FAMILIAL BENIGN HYPERCALCEMIA

The study will attempt to localize, by molecular genetic linkage analysis, an autosomal monogenic alteration which causes familial benign hypercalcemia and ultimately clone and express the abnormal gene.